Pubertal development, stress system functioning, and addiction vulnerability

PROJECT SUMMARY
The proposed career development application aims to provide research training for Dr. Elizabeth Kwon,
supporting her transition to independence as a transdisciplinary scientist. Dr. Kwon's long-term career goal is
to investigate the etiological risk and protective mechanisms of addiction vulnerability, with the ultimate goal of
contributing to the development of next-generation interventions. Her focus is on understanding the interplay
among psychological, physiological, and social factors driving addiction vulnerability during critical
developmental periods. Particularly, she is interested in stress system functioning as accumulating research
suggests dysregulation in neurobehavioral systems associated with the stress response operates as a key
mechanism conferring risk for addiction. This work has the potential to enhance preventive interventions by
elucidating physiological pathways connecting youth development and addiction. Dr. Kwon's proposed training
is structured to develop competencies in (a) multimodal assessment of stress system functioning, (b)
assessment of pubertal development and its interpretation across contexts and settings, and (c) professional
development. Alongside formal and informal educational experiences, Dr. Kwon will investigate the links
among pubertal development, stress dysregulation, and addiction vulnerability. In this research, Dr. Kwon aims
to explore the psychosocial determinants of the stress system functioning and its association with addiction
vulnerability. Her near-term goal (within 5 years) is to submit a competitive R01 application to the National
Institute on Drug Abuse (NIDA) for a prospective study investigating the transactions among childhood
adversity, pubertal maturation, trajectories of changes in stress system functioning, psychosocial
environments, and adolescents’ addiction vulnerability. The proposed proof-of-principal study is intended to
provide a focal point for training and preliminary data to support a competitive R01 application.

Public health relevance
PROJECT NARRATIVE Dysregulation in stress system functioning increases vulnerability to addiction (e.g., impulsivity, emotion dysregulation, early initiation of drug use). The proposed study will investigate the potential for environmental factors to affect stress system functioning during adolescence, a developmental period characterized by heightened neuroplasticity and sensitivity to contextual environments. This study will be part of a training program for a promising early-career scientist, aimed at advancing research on the interplay among pubertal development, stress system functioning, and drug use vulnerability.